Training in Translational Research in Alzheimer's and Related Dementias (TRIAD)

ABSTRACT
Our T32 training program entitled “Training in Translational Research In Alzheimer’s and Related Dementias
(TRIAD)” aims to provide cross-disciplinary training from bench to bedside, to produce a new translational
workforce that is critically needed to advance effective treatments for Alzheimer’s disease and related
dementias (ADRD). We will continue to support 4 predoctoral and 4 postdoctoral trainees who will receive
rigorous training through a transdisciplinary and integrative mentoring program that spans the discovery
continuum from molecular/ biochemical methods, preclinical translational approaches, and clinical research.
The thematic focus is on major ADRD risk factors, including cerebrovascular dysfunction, neuroinflammation,
brain injury, and genetic/lifestyle risks. The 23 faculty mentors include well-funded investigators with
established and extensive collaborative relationships and successful track records in training. The faculty
mentors encompass diverse yet complementary areas of expertise along the translational continuum from cell
and molecular biology, genetics, and data science, through preclinical model systems, therapeutic
development, neuroimaging, biomarkers, neuropathology, clinical trials, and longitudinal clinical studies. The
majority (20) of these mentors are faculty in the University of Kentucky Sanders Brown Center on Aging, which
includes a long-standing NIA-funded Alzheimer’s Disease Research Center (ADRC). The two-year training
plan will emphasize 1) experiential research and learning of core competencies required to become
independent leaders in clinical/ translational research, 2) a tailored educational plan that emphasizes the
translational continuum from basic science to clinical to community, and 3) multidisciplinary mentoring from
highly committed program faculty. Each trainee will develop an individualized development plan to enable
advancement to independent research and funding. Trainees will participate in a structured educational
program that includes a dedicated AD101 course, training in the responsible conduct of research, Good
Research Practice training, data science, and workshops and seminars. Trainees will gain career development
experiences through the monthly trainee-organized team meeting, presentations at the annual Markesbery
Symposium on Aging and Dementia, and grant writing workshops. Trainees will also have the opportunity to
participate in an experiential learning externship, which can include an off-site training course, visiting a
collaborator’s lab to develop additional research skills, or visiting another ADRC to observe/shadow/learn
specific aspects based on the trainee’s research interests. Quantitative and qualitative metrics for evaluation of
trainees, mentors, and the training program will assure a high-quality and effective training experience. Overall,
this T32 program is uniquely positioned to fill a growing need for a diverse, translational research workforce
with the cross-disciplinary team science skills required to conduct rigorous and cutting-edge basic,
translational, and clinical research to develop and advance effective interventions for ADRD.

Public health relevance
NARRATIVE Our training program for “Translational Research In Alzheimer’s and Related Dementias (TRIAD)” will provide predoctoral and postdoctoral trainees with the cross-disciplinary knowledge and skills needed to discover, develop, and advance new treatments for Alzheimer’s disease and related dementias. Trainees will be provided with expertise in cutting edge approaches from molecular methods to preclinical approaches and translation to clinical research. Our highly collaborative, interdisciplinary, and supportive team-based environment at the University of Kentucky will produce the skilled workforce that is critically needed to conduct basic, translational, and clinical research for Alzheimer’s disease and related dementias.